MOT089 EFFECT OF GRADED SRIH INFUSION ON GH RELEASE IN FASTED SUBJECTS

Increasing hypothalamic somatostatin secretion is one of the causes of the aging-related fall in growth hormone secretion. As a result, the dose of exogenous somatostain needed to suppress growth hormone secretion will be greater in older than young adults.